The impact of the Supplemental Nutrition Assistance Program on the cardiovascular health of low-income adults

PROJECT SUMMARY/ABSTRACT
Food insecurity—the economic and social condition of inconsistent access to healthy food—is associated with
worse cardiovascular health. Whether food assistance related social policies can improve cardiovascular
health among low-income adults in the US is unknown. The Supplemental Nutrition Assistance Program
(SNAP) is the largest US government-funded program providing food assistance. In 2021, at the cost of
approximately $114 billion, 41.5 million Americans received SNAP benefits. As SNAP is administered by
individual states, there are variations in policies related to eligibility assessment and ease of application that
significantly impact participation levels. Although SNAP participation has been associated with improved food
security, poverty reduction, and lower healthcare expenditures, it's impact on cardiovascular health is
unknown. The mechanisms by which SNAP, and poverty reduction programs in general, influence
cardiovascular health is unknown, but may be mediated through mechanisms such as medication adherence
and psychosocial stress. In a previously published analysis, we found that implementation of state level
policies associated with higher SNAP participation was associated with slower growth in diabetes prevalence.
However, whether SNAP participation, or the policies impacting this participation, impacts cardiovascular
health at an individual level is unknown. During the COVID-19 pandemic, the amount of SNAP benefits
received by participants increased, but some of these increases are scheduled to expire. How SNAP benefit
amounts impact cardiovascular health related measures is therefore important to understand. Aim 1 of the
proposed research will use data from a nationally representative survey of older adults – the Health and
Retirement Study (HRS) – linked with Medicare or Medicaid administrative claims data to identify whether
SNAP participation among low-income individuals with cardiovascular disease is linked with improvements in
medication adherence and psychosocial stress as well as lower healthcare utilization. Aim 2, using Medicare
and all-payer claims data, will examine whether changes in state-level SNAP policies associated with SNAP
participation lead to changes in the incidence of acute cardiovascular events among low-income adults. We will
also study whether specific policy categories are associated with a greater change in health outcomes. In Aim
3 we will examine how changes in SNAP benefit amounts influence cardiovascular health-related measures.
We will examine the temporary increase in SNAP benefit amounts that occurred nationwide from 2009 to 2013
as a result of the Recovery Act of 2009 and evaluate whether these changes resulted in differences in
medication adherence, healthcare utilization, and health outcomes among SNAP participants with
cardiovascular disease. The proposed research aims will require robust causal inference techniques to
disentangle the effect of SNAP from other potential confounders. This research will provide important insights
to policymakers regarding the potential public health benefits of investments in food assistance programs.

Public health relevance
PROJECT NARRATIVE Low-income individuals experiencing food insecurity – the economic and social condition of inconsistent access to healthy food – have a disproportionately higher burden of cardiovascular disease. This study aims to understand whether participation in the Supplemental Nutrition Assistance Program (SNAP) – the largest government funded food assistance program in the US – is linked with improvements in cardiovascular health for low-income individuals. The findings of this study will also identify which SNAP-related policies can potentially impact cardiovascular health outcomes, which is particularly relevant in light of the many changes the program has undergone during the COVID-19 pandemic.